Mechanisms and Modulation of Accelerated Atherosclerosis in Clonal Hematopoiesis

Project Summary/Abstract
With age, humans can accumulate leukocyte clones in blood that arise from somatic mutations in bone marrow
stem cells that enhance expansion: clonal hematopoiesis of indeterminate potential (CHIP). Mutations in
DNMT3A and TET2 account for the plurality of these clones. CHIP confers highly elevated cardiovascular (CV)
risk, independent of traditional risk factors. We have found accelerated atherogenesis and the involvement of
IL-1 and IL-6 in mice with myeloid loss of Tet2 or Dnmt3a function and that genetically reduced IL-6 signaling
abrogates the elevated CV risk in humans with DNMT3A or TET2 CHIP. Analyses of our CANTOS trial showed
greater efficacy of IL-1β inhibition in humans with DNMT3A or TET2 CHIP. These results point the way to a
genotype-directed allocation of therapy, an approach that has transformed oncology but remains aspirational in
atherosclerosis. The roles of classical vs. trans IL-6 signaling in atherothrombosis requires further study due to
conflicting evidence. Specific aim 1 will test the hypothesis that atherosclerotic mice that mimic CHIP due to
myeloid deficiency in Dnmt3a treated with an antibody that interrupts global IL-6 signaling by neutralizing IL-6
receptor α (IL-6r, CD126) have decreased atherosclerosis and inflammation within the lesions, blood and other
organs as gauged in part by single-cell RNA sequencing (scRNA-seq). We further hypothesize that IL-6r
inhibition will limit expansion of the mutant clone. Specific aim 2 will probe the role of classical vs. trans IL-6
signaling in myeloid cells in accelerated atherogenesis in CHIP using Il6rflox/flox/Lyz2-Cre mice bone marrow
chimeric LDLR-/- mice (to block leukocyte classical signaling), and administration of a gp130-IgG1-Fc chimeric
protein (to block trans signaling) using similar procedures and endpoints. The results will illuminate the
controversy and unsettled science regarding the contributions of classical and trans IL-6 signaling to
atherogenesis. Specific aim 3. Our preliminary experiments show that female myeloidTet2-/-Ldlr-/- mice have
greater acceleration of atherogenesis than Tet2+/+ Ldlr-/- male mice and, unlike their male counterparts, show
reduced atherogenesis with IL-1β neutralization. We will localize where this sex difference operates in the
inflammasome–IL-1β–IL-6 pathway, and test the hypothesis that female Dnmt3a-/-Ldlr-/- mice have greater
response to IL-6r inhibition than males. We will probe mechanisms by gonadal ablation experiments and by
analysis of scRNA-seq data, which in preliminary data shows IL-1β expression in resident macrophages cells
from atheroma from Tet2-/- females but not males. This work will deepen understanding of the mechanisms of
accelerated atherosclerosis in CHIP. Our new pilot clinical data show that an anti-IL-6 antibody can mute
inflammation in humans. Thus, the work proposed here will provide an indispensable step toward validating
and furnishing the fundamental basis of an immediately translatable targeted therapeutic strategy based on
CHIP genotype.

Public health relevance
PROJECT NARRATIVE With age humans can accumulate clones of leukocytes in peripheral blood that arise from somatic mutations in bone marrow stem cells: clonal hematopoiesis of indeterminate potential (CHIP). Mutations in DNMT3A or TET2 account for most CHIP, and associate with a striking 2-4 fold excess in atherosclerotic events, but we have little understanding of the underlying mechanisms. This study will investigate in mice bearing CHIP mutations in myeloid cells mechanistic hypotheses about the causality of interleukin (IL)-6 and IL-1 signaling and sex differences in accelerated atherosclerosis in Tet2 and Dnmt3a hypofunction, building on decades of our group's experience with cytokine biology in atherothrombosis in both basic and clinical investigations, an offers strong translational potential.